Dependence of radiosensitivity of lymphocyte subtypes on proton dose and LET and its impact on immune suppression

Project Summary
Radiation-induced lymphopenia (RIL) is a common adverse effect of radiation therapy. Recent studies have
shown that the development of severe (grades 3 or 4) RIL has a significant detrimental association with overall
survival. RIL is also associated with reduced efficacy of anti-PD1 immunotherapy, which is concerning because
of the considerable potential of combining radiation therapy with immunotherapy in order to take advantage of
the immunostimulatory effects of radiation. Therefore, it is important to better understand the mechanisms of RIL
in order to reduce patient risk. Clinical studies by our team have demonstrated that proton therapy, because of
its compact dose distributions, leads to significant reduction in severe RIL and to improved outcomes. The long-
term goal of this research is to be able to predict which patients are more likely to develop severe RIL and
produce optimized proton treatment plans that will reduce this risk. The objective of this study is to understand
how proton linear energy transfer (LET), in addition to dose, contributes to the death of lymphocytes and their
subtypes. The compact dose distribution from proton therapy should theoretically reduce the incidence of RIL,
but higher LET outside of the treatment site may diminish this advantage. This may explain why some studies
have shown reduced incidence of RIL when the patient is treated with protons while other studies have not
shown this association. The role of LET in lymphocyte death and RIL has been largely ignored. Currently, there
are no data, to our knowledge, on the sensitivity of lymphocytes to LET. Further, none of the current lymphopenia
risk models incorporate LET and it is not used as a parameter for plan evaluation at most proton centers. In Aim
1, I will characterize the sensitivity of lymphocytes and their subtypes to radiation dose and LET using a
specialized irradiation device to expose lymphocytes simultaneously to a range of doses and LETs. In Aim 2, I
will incorporate LET into the RIL risk prediction model that has been developed by our lab and test if this improves
the model’s predictive power. In Aim 3, I will develop the methodology to utilize LET-guided treatment
optimization, considering differential radiosensitivity of lymphocyte subtypes on LET, and assess the
effectiveness of this approach for RIL risk reduction. With well regarded expertise in proton therapy and a strong
medical physicist training record, the Mohan lab is an ideal environment for me to complete the proposed
research. Throughout my graduate training, I will work collaboratively with several renowned scientists in multiple
fields including medical physics, immunology, radiobiology, and bioinformatics from MD Anderson and our
collaborating institutions. I will have access to world-class facilities including a proton center to conduct my
research. Additionally, I will submit four first-authored publications, present my work regularly, and attend
national and international conferences. I will also take additional coursework on immunology and bioinformatics
and learn about the clinical roles of medical physicists through specialized clinical training and shadowing.

Public health relevance
Project Narrative Radiation induced lymphopenia (RIL) is a common side effect of radiation therapy and has been shown to be associated with reduced overall survival and diminished effectiveness of immunotherapy. This research aims to investigate the dependence of radiosensitivity of lymphocytes, the cells of the immune system, and their subtypes on proton radiation dose and linear energy transfer (LET), which is the average energy deposited per unit track length, in contributing to RIL. Understanding how different subtypes respond to dose and LET could potentially allow prediction of severe RIL risk in patients and optimization of their proton radiation treatment plans for most favorable outcomes.